TAS::75 0862::TAS MATHEMATICAL/STATISTICAL ANALYSES

The NIEHS and the National Toxicology Program (NTP) at NIEHS conduct a variety of studies that require data analysis and statistical, mathematical and computational support. The objective of this contract is to provide the needed support for the research activities of NIEHS and NTP at NIEHS, including laboratory experiments and human studies. This support contributes to the efforts of NIEHS and NTP to produce high quality research that fulfills the missions of reducing the burden of human disease and disability, identifying substances that affect human health and understanding how the environment affects human health. The research is made available to the public as peer-reviewed journal articles, peer-reviewed technical reports, fact sheets, websites and other publications.